Pathways in Genomics Research Experiences for Undergraduates from Underrepresented Groups

Project Summary/Abstract
There is a critical need for genomics scientists across the United States, especially in Colorado
and Metro Denver, where there is a growing hub of genomics innovation and research in
academia and industry. Additionally, diversity in the genomics workforce is necessary to support
creativity, study health conditions in underrepresented groups, and ensure that genomics
research is generalizable and beneficial to all people. This long-term goal to ensure that
genomics research can be applied across all populations will contribute to the mission of NIH to
enhance health, lengthen life, and reduce illness and disability among underrepresented
groups.
The proposed Pathways in Genomics Research Experiences for Undergraduates (PATH-
GREU) from underrepresented groups will help meet this need by preparing diverse genomics
scholars for careers or further education in genomics. Undergraduate students from
Metropolitan State University of Denver (MSU Denver) will complete research at the University
of Colorado – Denver (UCD) Downtown Campus (DTC) and Anschutz Medical Campus (AMC)
that house world renowned biomedical and human genomics research laboratories. Pairing
MSU Denver with UCD is ideal as the two institutions are co-located at the Auraria campus in
downtown Denver and are less than 10 miles from the University of Colorado Denver
Anschutz Medical Campus. The PATH-GREU Program will: (1) Recruit undergraduate
students from diverse demographic groups underrepresented in genomic research; (2)
Establish a rigorous genomics research training program and supportive learning community
that strengthens scientific understanding and promotes professional skills acquisition; and (3)
Create a life-long community and mentorship network that enables scholars to embrace their
identity as scientists and advance their careers in genomics. In doing so, PATH-GREU will
build and support a diverse genomics scholar community within Metro Denver and
Colorado.

Public health relevance
Project Narrative A diverse community of genomic scientists are needed to fully support biomedical research and translation into the clinic. To train the next generation of genomic scientists, we present a partnership between the diverse, Hispanic-serving Metropolitan State University of Denver with the world-renowned genomics research at the University of Colorado Denver’s Downtown and Anschutz Medical Campuses. As part of the “Pathways in Genomics Research Experiences for Undergraduates (PATH-GREU) from underrepresented groups” program, we will recruit, train, and build a community of genomic scientists from groups traditionally underrepresented in biomedical research.